Integrating Genomic Signatures with Functional Analysis of DNA repair

PROJECT SUMMARY Genome instability is the underlying cause of many diseases including premature
aging, neurodegeneration, cancer, and immunodeficiency. Genome integrity is maintained by at least six major
DNA repair pathways, each of which specializes in the repair of distinct types of DNA damage or replication
errors. Inefficient DNA repair in any of these pathways can lead to the accumulation of DNA damage,
mutations, and disease. Thus, to study the mechanisms by which DNA repair protects against disease, we
need to know the status of all DNA repair pathways in human cells. Mutational signatures provide valuable
insights into DNA repair, but they have several important limitations. Mutational signatures may not reflect the
current status of DNA repair, and the bulk sequencing most commonly used to measure mutational signatures
can miss important cell-to-cell heterogeneity. Furthermore, the relationship to the functional status of DNA
repair remains poorly understood for many mutational signatures. Direct measurements of DNA repair would
overcome these obstacles, but technology capable of the necessary large-scale functional analyses of DNA
repair have not been available. We will address this long unmet need by developing high-throughput functional
assays and an advanced analytical framework for single-cell resolution measurements of all major DNA repair
pathways. Our strategy is based on our well-established and widely applied fluorescence multiplex host cell
reactivation (FM-HCR) assays, which report the ability of cells to repair site-specific DNA lesions incorporated
into fluorescent reporter plasmids. Using a sequencing approach (HCR-Seq) that is firmly established in our
preliminary data, we will generate a library of reporter plasmids that can signal DNA repair capacity by a
change in the abundance or sequence of a reporter transcript, instead of a fluorescent signal. Following
transient transfection of 500 cell lines (transfected in 20 pools of approximately 25 cell lines each), reporter
transcripts and host cell transcriptomes will be analyzed by single-cell RNAseq. The resulting dataset will
generate an unprecedented resource: comprehensive multi-pathway DNA repair analyses with single-cell
resolution in 500 highly characterized cell lines that are part of the Cancer Cell Line Encyclopedia. This dataset
will be integrated with existing sequencing and proteomics data to identify relationships of DNA repair capacity
with mutational signatures, genomic and epigenomic somatic alterations, and gene and drug dependencies.
The dataset will also provide an unprecedented view of cell-to-cell heterogeneity with respect to DNA repair
that can be interpreted in the context of host cell transcriptomes, as we have shown for cell cycle-dependent
regulation of DNA repair. Our dataset and approach will be shared with the scientific community in the Broad
DepMap Portal to advance future projects aimed at understanding the biological mechanisms underlying
genome instability and the potential for translational work aimed at predicting and preventing its consequences
for human health.

Public health relevance
PROJECT NARRATIVE Genomic signatures provide insights into past mutational processes driven by DNA damage and repair, but they may not reflect the current status of DNA repair pathways in individual cells. A lack of functional assays has hampered efforts to understand the relationship between DNA repair and mutation signatures. We are therefore developing a high-throughput platform for measuring the activity of all major DNA repair pathways in hundreds of cell lines.